Role of Extracellular Vesicle: Autophagy Pathway Crosstalk in Type 2 Diabetes Pathogenesis

PROJECT SUMMARY/ABSTRACT
The prevalence of Type 2 diabetes (T2D) is an expanding global issue that continues to impact several
developing nations. The onset of pancreatic β-cell functional failure is a central feature to the pathophysiology
of T2D and is mediated in part by diabetogenic stressors including chronically elevated free fatty acids
(lipotoxicity), low-grade systemic inflammation, and proteotoxicity. Due to their high protein synthetic burden, β-
cells employ autophagy and endo/lysosomal pathways to reduce protein aggregates and protect β-cell mass and
function. Recently, two endomembrane systems – small extracellular vesicles (sEVs; 30-150 nm sized
nanoparticles) and autophagy have been shown to work in tandem to facilitate cellular adaptation and
intercellular communication. Under diabetogenic stress, β-cell defects in autophagy mediated by auto/lysosomal
dysfunction have been shown to occur, while conversely our group and others have noted enhanced sEV
secretion in these conditions. However, what remains elusive is our understanding of the molecular mechanisms
underlying the dis-balance between autophagy and sEV secretory pathways and potential therapeutic strategies
to re-balance both in order to improve functional β-cell mass. Thus, our central hypothesis is that diabetogenic
stress-mediated β-cell lysosomal dysfunction occurs in part, through activation of a novel secretory autophagy
pathway to enhance β-cell sEV secretion. In Specific Aim 1, we will use in vitro and ex vivo, mouse and human
diabetic models to investigate the molecular mechanisms associated with diabetogenic stress-mediated
enhanced β-cell sEV secretion through activation of a novel sEV-based secretory autophagy pathway. We will
use state-of-the-art EV based tools and technologies to visualize and quantify events that will determine
activation of secretory autophagy. Furthermore, we will use sophisticated cell biology techniques to delineate
the mechanism of preferential β-cell sEV release mediated by diabetogenic stress-induced amphisome de-
acidification events. Our preliminary data reveal significant improvements in β-cell function and a reduction in β-
cell sEV concentration under diabetogenic stress with pharmacological agents to either repress sEV
biogenesis/release or enhance autophagy. Thus, in Specific Aim 2, we will explore in vivo and in vitro
pharmacological, nutritional, and genetic therapeutic approaches to rebalance sEV secretory:autophagy
pathway flux under diabetogenic conditions with the goal of improving functional β-cell mass. Using these
approaches, we will first test the impact of a) inhibition of sEV biogenesis/release; b) enhancing autophagy; c)
using a combinatorial approach to determine alterations in sEV release, autophagy induction, and β-cell function.
Taken together, completion of the proposed application will provide novel insight into the molecular mechanisms
that regulate sEV biogenesis and autophagy crosstalk during β-cell functional failure in T2D. Moreover, these
studies will uncover new potential therapeutic approaches to restore the balance between both pathways with
the goal to preserve and/or restore functional β-cell mass.

Public health relevance
PUBLIC HEALTH RELEVANCE/NARRATIVE Type 2 diabetes (T2D) is one of the largest global epidemics to plague developing nations with global estimates of one in ten adults having diabetes. Therefore, a better understanding of the molecular mechanisms that contribute to T2D pathogenesis is needed in order to design and implement novel therapeutics and biomarker discovery for the prevention and treatment of this disease. The overall goal of this proposal is to elucidate a novel molecular dis-balance between two associated pathways – extracellular vesicle biogenesis and autophagy along with novel treatment strategies to re-balance both pathways to mitigate β-cell failure in T2D.